Regulation of Lipid Catabolism by Autophagy in Neural Stem Cell of Tuberous Sclerosis Complex

Tuberous sclerosis complex (TSC) is a genetic disorder affects as many as 50,000 people in US. TSC
often affects brain by seizures, autism, intelligence instability and growth of noncancerous (benign) tumors.
These defects persist in neonatal and adult brains of TSC patients. The mutations of Tsc1 or Tsc2 gene
leading to the loss of their tumor suppressor functions to control the activity of mTORC1 underlie the
pathogenesis of TSC. mTORC1 is an established master regulator of cellular homeostasis and stimulates
the activity of translation but negatively regulate autophagy, a conserved catabolic process that degrades
cytoplasmic constituents and organelles in the lysosome. Interestingly, ours recent findings revealed a
higher autophagy activity in Tsc1-deficient cells under energy stress conditions, leading to establishment of
a novel double conditional knockout (cKO) mouse model to delete TSC1 and FIP200 (Fak interaction protein
of 200 KD, an essential component in autophagy induction complex) in postnatal neural stem cells (NSC).
Using this unique model, we revealed the essential functions of autophagy to sustain high mTORC1 activity
and in abnormal postnatal development of Tsc1-deficient NSC. In addition, we found that autophagy was
required for mitochondria oxidative phosphorylation to resist energy-stress conditions, most likely providing
free fatty acids to generate ATP from intracellular lipid storage. These pilot findings form the basis of our
hypothesis that autophagy mediates the lipids degradation in Tsc1-deficient NSC for β-oxidation and ATP
production to maintain their high mTORC1 activity, which provide a valuable metabolic target for TSC
patients. In Aim1 of this proposal, we will exam the molecular and metabolic mechanisms of autophagy in
lipid degradation and the functions of lipophagy to regulate signaling pathways for high mTORC1 activity,
using primitive and differentiating NSC. In Aim2, we will use our newly developed FIP200 conditional
knockin mouse which is defective in binding with Atg13 to generate Tsc1/Fip200 2cKI mice. This genetic tool
will further clarify the mechanisms of lipophagy in Tsc1-deficient NSC. We will also adopt pharmacological
methods to target autophagy mediated lipid catabolism to treat defects in postnatal Tsc1-deficient NSC. In
Aim3, we will generate novel inducible mouse models to specifically deplete Tsc1 and Fip200 in postnatal
NSC. We will also use these mouse models to treat existing SEN/SEGA, which is more clinically relevant, to
complement studies in Aim2. At the end of these studies, we will expand our knowledge of pathogenesis in
TSC-deficient NSC, identify candidate signaling pathways and metabolic alterations by hyperactivated
mTORC1, and develop new therapeutic concepts for continued investigation in the treatment of brain
development disorders in TSC patients.

Public health relevance
Tuberous sclerosis complex (TSC) is a multi-system developmental disorder with prominent malformations and benign tumors in postnatal brain. Our proposed research aims to determine the molecular and metabolic mechanisms of lipophagy for hyperactivated mTORC1 signaling in TSC-deficient neural stem cell. The proposal has strong clinical relevance for developing novel targeted therapies to treat TSC patients and other hyperactivated mTORC1 associated diseases.